Sensory Mechanisms and Disorders

Project Summary
This training program for predoctoral students and postdoctoral fellows provides an interdisciplinary education
and research experience in hearing, balance and chemical senses (HBCS). Predoctoral training is based in one
of the 15 academic departments and degree-granting graduate programs with which the 21 training faculty are
associated. Doctoral thesis research and postdoctoral research training reside primarily within the laboratories
of the mentors. Our affiliated faculty provide outstanding training in each of their corresponding disciplines:
bioengineering, cellular and molecular biology, genetics, neurophysiology and optogenetics, developmental
biology, and biopsychology of sensory processing. The HBCS program integrates investigators in auditory,
vestibular, and chemosensory research with trainees from across these disciplines and thereby fosters
innovative training opportunities into mechanisms and disorders of hearing, balance, and taste and olfaction.
Cross-disciplinary integration is made possible by the training program through: a) introductory and advanced
courses in sensory systems; b) seminars relevant to hearing, balance and chemical senses from experts within
and outside the University of Michigan; c) student and faculty seminars, journal clubs and research forums; d)
exposure to clinical research issues in Otolaryngology and clinical/translational resources available at the
University of Michigan Medical School, and e) training in research standards and ethics. In addition, mentee
projects usually include a co-mentor from a different laboratory within or across departments to provide
complementary expertise. There is a strong emphasis on equity and diversity, which is fostered by bimonthly
meetings for women and minority students. Support for 4 predoctoral and 3 postdoctoral trainees is requested.
Predoctoral trainees will be selected from the most highly qualified graduate students in the training faculty's
affiliated departments and programs. Interest and motivation for research in sensory systems will be an important
selection criterion. Postdoctoral trainees (Ph.D., M.D., or D.D.S.) will be selected from applicants with a strong
commitment to sensory biology and promising research backgrounds.

Public health relevance
Project Narrative Our primary goal for this training program is to attract promising scientists to the research fields of hearing, balance, taste and smell, and to provide them with the mentoring and training that will result in their pursuit of important new knowledge through productive research careers in these areas. A better understanding of these sensory systems will provide important insight into many human disorders that greatly affect quality of life and will lead to new therapeutic treatments.